Integrated Food Safety System Online Research and Collaboration Development

Project summary and narrative not required per the RFA.

Public health relevance
Project summary and narrative not required per the RFA.